Humanized mice as a model to study novel therapies for HIV-Associated Neurocognitive Disorders (HAND) in elderly HIV-1 infected individuals

PROJECT SUMMARY/ABSTRACT Increased comorbidities such as HIV-associated neurocognitive disorder (HAND) are an emerging problem in HIV-1 infection but the mechanisms are unclear. Understanding the mechanisms by which inflammation and chronic immune dysfunction in chronic HIV infection drive HAND despite potent antiretroviral therapy (ART), will provide new therapies to reduce HIV-1 related morbidity. Statins are inadequate treatment for HIV-1- related inflammation, immune activation and comorbidities and novel therapies are needed. Novel therapies such as apoA-I mimetic peptides that target oxidative stress and oxidized lipids can complement statins and can be promising therapies for HIV-1 related comorbidities. Before these novel therapies are tried in the clinic, the exact mechanisms of action need to be defined. While several human studies have studied HIV-1 related comorbidities related to aging such as HAND, they are all limited by several confounders. Given the complex pathogenesis of HAND, it is impossible to directly study in humans mechanisms that drive HAND. A robust animal model is needed to understand HAND. The humanized mouse model represents to date the most advanced in vivo model to study HIV pathogenesis and has been used to study HAND. The immunodeficient mice that undergo bone marrow/liver/thymus (BLT) transplantation have better engraftment of human hematopoietic stem cells than any other mouse strain. We hypothesize that the BLT mice can be used as a model to directly study therapies for HAND. It is becoming clear that macrophage/monocyte (M/M) dysfunction (activation and aging called senescence) may accurately predict morbidity and mortality in ART-treated individuals. Thus, the current proposal will explore whether the BLT mouse can be used as a model to study whether apoA-I mimetic peptides can complement statins to attenuate proinflammatory/activated/senescent M/M (peripheral blood) and brain inflammation (known to contribute to HAND) related to HIV-1 and human M/M. Given that HIV-1-infected persons on ART may continue to have HAND such an approach could reduce the excess morbidity and mortality remaining despite ART. This work is innovative, has a potential impact on public health and directly addresses NIH's overarching HIV/AIDS research priorities regarding HIV-associated comorbidities (NOT-OD-15-137). This grant application also directly addresses the scope of this R03 grant that encourages pilot or feasibility studies, innovative research and development of new research technologies (novel therapies for HAND within a physiologically relevant mouse model).

Public health relevance
RELEVANCE TO PUBLIC HEALTH Understanding the mechanisms by which inflammation and chronic immune dysfunction in chronic HIV infection drive HIV-Associated Neurocognitive Disorders (HAND) despite potent antiretroviral therapy (ART), may pave the way for novel therapeutic interventions that may improve morbidity in HIV infected persons. This research proposal is designed to investigate whether humanized mice can be used as a robust animal model to study novel therapies (statins, apoA-I mimetic peptides) for HAND that is often present in elderly HIV-1 infected individuals. This work is innovative, may have a potential impact on public health and directly addresses research priorities regarding HIV-related comorbidities despite effective antiretroviral therapy.